Targeting BDNF Using Atomoxetine for the Treatment of Obesity Caused by MC4R Insufficiency

Project Summary/Abstract:
Targeted therapies for the treatment of monogenetic obesity are essential because typical lifestyle
interventions and standard anti-obesity medications are largely ineffective as they do not correct the specific
genetic defect causing abnormal energy balance. The leptin pathway is the key regulator of body weight
through control of appetite and energy expenditure. In particular, the severe insatiable hunger experienced by
patients with leptin pathway disorders leads not only to extreme obesity, but the unrelenting drive to seek food
also causes substantial distress for patients and their caregivers. While therapies have been developed for
treating genetic disorders affecting the proximal portion of the leptin pathway (LEP, LEPR, POMC, PCSK1, and
BBS1-22), there are no treatments for loss-of-function LOF) variants of the melanocortin-4 receptor gene
(MC4R), which cause melanocortin obesity syndrome (MCOS). In various population and cohort studies, 1-6%
of patients with severe, early onset obesity are found to have MC4R LOF variants, making MCOS the most
common cause of genetic obesity. Brain-derived neurotrophic factor (BDNF) is a downstream mediator of
MC4R signaling and therefore may serve as a specific target for MCOS treatment. We propose repurposing a
well-understood and commercially available attention-deficit hyperactive disorder (ADHD) medication,
atomoxetine, for the treatment of MCOS, because of animal and human studies showing that this drug induces
endogenous BDNF levels. We hypothesize that atomoxetine will increase hypothalamic BDNF levels, leading
to weight loss through improved anorectic signaling downstream of the abnormally functioning MC4R. To test
our hypothesis, we propose to conduct a phase 2 randomized, placebo controlled, crossover trial in 20 patients
with MCOS age ≥ 6 years. The primary outcome measure will be change in BMI (expressed as the percentage
of the 95th percentile BMI for age/sex). Additional measures will include percent body fat and visceral fat area
by bioelectrical impedance analysis, resting energy expenditure by indirect calorimetry, dietary intake by food
frequency questionnaire and 24 hour recall, hyperphagia score, hunger level, satiety level, hemoglobin A1c,
lipid panel, liver function tests, blood pressure, heart rate, and ADHD symptoms. Serum and plasma BDNF and
genetic variants in atomoxetine metabolism enzymes will be assessed and correlated with weight changes.
This pilot clinical trial will provide valuable data on the safety and efficacy of atomoxetine for treating MCOS,
and the data will be used to guide the design of a future phase 3, multicenter, randomized clinical trial.

Public health relevance
Project Narrative: We propose to conduct a phase 2 randomized placebo-controlled crossover trial to determine the safety and efficacy of atomoxetine for treating obesity caused by loss-of-function variants in the melanocortin-4 receptor (MC4R), the most common cause of genetic obesity disorders. Atomoxetine was selected for this pilot trial because it has been shown to increase brain-derived neurotrophic factor (BDNF) within the central nervous system and in peripheral circulation. Targeting BDNF is a specific strategy for treating MC4R abnormalities because BDNF functions as a downstream mediator of MC4R signaling.